Mechanistic studies of a bifurcating flavoprotein

Project Abstract Electron-transferring flavoproteins (ETFs) are a large and broadly distributed family of electron carriers that play critical roles in a variety of metabolic processes, including β-oxidation of fatty acids in humans. Defects in ETFs give rise to several specific disease states. A subset of the ETF family constitute a recently discovered class of complex flavoproteins that catalyze the coupled reduction of high- and low-potential electron acceptors using a median-potential electron donor in a process referred to as electron bifurcation. An example of such a bifurcating ETF is the EtfABCX system from Pyrobaculum aerophilum. This enzyme accepts reducing equivalents from NADH, passing the reducing equivalents on to the high-potential menaquinone and the low-potential iron- sulfur protein ferredoxin in a manner that is overall thermodynamically favorable. The proposed work will examine in detail the kinetics of electron bifurcation as catalyzed by EtfABCX, critically evaluating the involvement of protonation/deprotonation processes associated with the primary electron transfer events.

Public health relevance
Project Narrative The menaquinone-dependent NADH:ferredoxin oxidoreductase EtfABCX is a complex flavoprotein that catalyzes the coupled reduction of the high-potential electron acceptor, menaquinone, with that of the low-potential acceptor, the iron-sulfur protein ferredoxin, using the median-potential electron donor NADH in a process referred to as electron bifurcation. It is a member of a broadly distributed family of electron-transferring flavoproteins and is closely related to the mitochondrial ETF in humans. The ultimate goal of the proposed work is to understand in detail how electron transfer occurs, and thereby inform the molecular basis of human disease states involving dysfunction in electron transfer.